Non-immunosuppressive rheumatoid arthritis DMARD

ABSTRACT
This proposal is focused on development of a novel non-immunosuppressive biologic therapy for RA by targeting
fibroblast-like synoviocytes, local joint-lining cells that substantially contribute to joint destruction during
rheumatoid arthritis (RA). The development of immunosuppressant disease-modifying anti-rheumatic agents
(DMARDs) has dramatically improved the quality of life of RA patients; however a large proportion of patients
still fail to reach sufficient control of disease activity on the currently available RA medications. There is a need
for novel non-immunosuppressive therapies for RA that can be used alone or in combination with current
DMARDs. To address this need, we are seeking to target fibroblast-like synoviocytes as a non-
immunosuppressive option for RA. Here, we will demonstrate our biologic reduces FLS migration and invasion
and reverses arthritis in mice. This project addresses a major unmet medical need in RA, the lack of non-
immunosuppressive therapies for controlling disease activity. Once we obtain proof-of-concept data during this
Phase I project, we will apply for Phase II funding to further develop the lead and characterize its preclinical
efficacy and safety.

Public health relevance
NARRATIVE We propose a Phase I plan for early development of a novel biologic therapy for rheumatoid arthritis that would act directly on cells in the joint without causing immunosuppresion. In rheumatoid arthritis there is a strong unmet medical need for non-immunosuppressive medications that can be used alone or combined with currently available treatments. The objective of this proposal is to address this need by developing a novel non- immunosuppressive therapy that acts by targeting joint-lining cells rather than suppressing the immune system.